Dysfunctional Orexin-Regulated Neural Circuits in Alzheimer's Disease

Persons with Alzheimer's Disease (AD) experience spatial disorientation that emerges early in the disease
process. In both humans and rodent models of AD, dysfunction within the retrosplenial cortex (RSC), a crucial
locus for spatial navigation and memory, is observed prior to the onset of cognitive decline. Understanding the
mechanisms underlying RSC dysfunction is important to develop strategies aimed at improving spatial
navigation and memory in AD. We observe aberrant RSC network activity that includes reduced RSC rhythmic
synchrony during spatial navigation in a mouse model of AD, yet the cellular and molecular basis for these
defects are unknown. Here, using a newly developed mouse line, we identify a specific population of RSC
neurons that express the orexin 1 receptor (RSCOX1R) and are activated by the neuropeptide orexin. In WT
mice, direct stimulation of these RSCOX1R neurons enhances RSC synchrony, suggesting these neurons are an
important population in which to examine cellular mechanisms of AD-related RSC dysfunction, and to target for
therapeutic intervention. Orexin signaling affects numerous physiologic processes, including spatial memory,
and abnormalities in orexin signaling are implicated in AD pathology. Studies of specific orexin-regulated
memory circuits in AD is lacking, however. In this proposal, we examine whether RSCOX1R neurons are directly
altered in the 5xFAD model of AD (Aim 1). We also test the hypothesis that the activation of RSCOX1R neurons
or enhancement of orexin-signaling/regulation of RSC neurons can restore the AD-associated deficits in RSC
rhythmic activity (Aim 2). The completion of this work will pave the way for larger-scale follow up studies across
multiple models of AD, with the potential to identify novel RSC and orexin-based therapies aimed at
ameliorating a range of spatial memory and cognitive deficits in persons with AD.

Public health relevance
Persons with Alzheimer's disease (AD) exhibit spatial disorientation during the early stages of the disease. The retrosplenial cortex (RSC), an area crucial for navigation and spatial memory, also shows dysfunction in early AD. These studies examine whether specific alterations in unique populations of neurons in the RSC contribute to its aberrant activity, and whether enhancement of RSC neuronal activity by the neuropeptide orexin can ameliorate RSC network dysfunction in a model of AD.